Role of sensory nerves in perivascular inflammation and vasomotor dysfunction with inflammatory bowel disease

Project Summary and Abstract
Inflammatory Bowel Disease (IBD) is an increasingly prevalent chronic disease marked by aberrant immune
responses and intestinal and extra-intestinal inflammation. IBD is comorbid with cardiovascular disease and
associated with decreased blood flow to the intestines, with a critical but poorly-studied role for the mesenteric
(MAs) arteries that regulate intestinal perfusion. Perivascular sensory nerves (PSNs) continuously innervate the
MA adventitia and perivascular adipose tissue (PVAT), regulating vasomotor function and facilitating blood flow
by dilating MAs and inhibiting sympathetic vasoconstriction. With IBD, these PSN functions are severely
impaired, and the PVAT that is normally anticontractile becomes procontractile through an unknown mechanism,
further impairing MA dilation. The sensory neuropeptides calcitonin gene-related peptide (CGRP) and substance
P (SP) may also be important in these IBD-related vascular dysfunctions, as they are linked to disease severity
and can mediate perivascular neuro-immune and neuro-adipose signaling through activation of local immune
cells. Previous work demonstrates that macrophages accumulate in both the MA adventitia and PVAT during
IBD, and macrophage depletion restores the ability of PSNs to dilate MAs and inhibit sympathetic constriction.
This suggests that perivascular macrophages can modulate arterial function with IBD, likely through a
mechanism involving sensory neurotransmitters in the adventitia and PVAT. What remains unclear is how
macrophages participate in PSN, PVAT, and blood flow dysfunction and when these changes occur in IBD
development. This project will test the overall hypothesis that PSN neurotransmitter released in adventitia and
PVAT of MAs promotes macrophage activation, accumulation, and inflammatory mediator release, leading to
vasomotor defects and impaired blood flow early in IBD pathogenesis. To investigate these relationships, the
immune-driven, Helicobacter hepaticus-induced IL10-/- mouse model of IBD will be used to address 3 research
Aims. Aim 1 will use confocal imaging, flow cytometry, and in vivo blood flow measurements at timepoints
throughout IBD development to determine when macrophage infiltration causes PSN and PVAT dysfunction and
impairs blood flow compared to the development of colon inflammation. Aim 2 will use sensory denervation and
transgenic mice lacking PVAT in conjunction with isolated artery preparations to determine whether the presence
and activity of PSNs and/or PVAT drive macrophage infiltration around MAs with IBD. Aim 3 will use advanced
imaging, primary adventitial and PVAT macrophages, and biochemical assays to test whether sensory
neuropeptides can activate macrophages from the MA adventitia and PVAT to release inflammatory mediators.
This project will uniquely define the role of PSNs and their signaling pathways in neuro-immune-adipose
interactions mediating vasomotor function, and it will determine how these pathways are affected during the
pathogenesis of IBD. Results will provide new insight towards developing selective therapeutic strategies for
treating vascular dysfunction and impaired intestinal blood flow to improve quality of life for IBD patients.

Public health relevance
Project Narrative Inflammatory Bowel Disease (IBD) is a chronic condition involving aberrant immune responses and recurring inflammation in the intestine and throughout the body. Patients with IBD are at risk for cardiovascular diseases, and, for unknown reasons, their mesenteric arteries do not properly regulate blood flow to the gut. The purpose of our project is to study how the perivascular nerves, immune cells, and adipose tissue around these arteries interact to regulate blood vessel function in health vs. IBD to identify new targets for the treatment of this debilitating disease.